Combination of formulated dolcanatide, a guanylate cyclase-C agonist, with formulated atiprimod, a JAK-STAT inhibitor, for treatment of murine colitis.

Abstract: Pathogenesis of inflammatory bowel disease (IBD) is typically initiated by the disruption of intestinal
barrier functions (IBF), causing imbalance in gut microbiome, leading to dysregulation in mucosal immune
responses, and eventually to development of ulcerative colitis (UC) or Crohn’s Disease (CD). Existing therapies
for IBD are not entirely satisfactory due to limited effectiveness as those are primarily anti-inflammatory or
immunomodulatory agents that are designed to control gastrointestinal (GI) inflammation. Guanylyl cyclase-C
(GC-C) is activated upon binding of guanylin (GN) or uroguanylin (UG), resulting in stimulation in cyclic GMP
(cGMP) production to stimulate fluid secretion in proximal intestine to normalize bowel movement. Beyond fluid
secretion in proximal intestine, activation of GC-C signaling by UG or GN also regulates IBF, epithelial cells
homeostasis (GI renewal process). PI’s group was the first to show that transcript levels of both UG and GN are
reduced dramatically in human colon polyps and adenocarcinomas, and that the dietary supplementation with
human UG not only inhibited polyp formation, but also delayed their progression to adenocarcinomas in Apc+/Min
mice. Subsequently, PI and several other researchers have shown that disruption in GC-C signaling, due to near
universal loss of GN and UG, leads to IBD and colorectal cancer (CRC). Thus, oral treatment with GC-C agonist
to overcome this deficiency represents a promising novel approach for treatment of UC & CRC. Indeed, orally
administered dolcanatide (dol), a superior analog of UG and a stable agonist of GC-C, ameliorated GI
inflammation in both chemical-induced, spontaneous models of colitis, and inflammation-induced CRC in mice.
These animal studies showed inverted U (bell) shaped therapeutic responses, raising a possibility that the higher
oral dose of dol might lead to excessive fluid secretion in the proximal intestine, resulting in ‘wash out’ of dol
before it could reach the target site colon. Thus, fluid secretion in proximal intestine could reduce its’ therapeutic
effect. In addition, GC-C signaling is also disrupted by the cytokine-mediated activation of JAK-STAT signaling
in GI inflammatory diseases. Thus, combination of dol with atiprimod (ati), a phase 2 clinically validated inhibitor
of cytokines mediated activation of JAK-STAT signaling, might produce superior therapeutic effects. PI
developed an oral formulation of drug-loaded chitosan microspheres (msf) that were sequentially coated with
time- and pH-dependent polymers to bypass proximal intestine such that the loaded drugs are released in distal
intestine to colon regions. This SBIR phase 1 grant is to evaluate msf-dol either alone or in combination with
msf-ati on severity of colitis in acute and chronic models of DSS-induced murine colitis. Colon tissues and blood
samples will be collected to assess treatment effects on GC-C and JAK-STAT signaling and on cytokine profiles.
Successful completion of these studies is expected to advance the msf-dol either alone or in combination with
msf-ati for further evaluations in the spontaneous and genetic models of UC, and in non-clinical IND-enabling
studies, as part of the planned SBIR phase 2 grant.

Public health relevance
Narrative Chronic inflammatory bowel diseases (IBD) such as Crohn’s disease (CD) and ulcerative colitis (UC) are multifactorial gastrointestinal (GI) diseases with high incidences worldwide, yet satisfactory treatment options are not available. Thus, microsphere-formulation of dolcanatide either alone or in combination with atiprimod offers a promising approach for UC treatment.